TRANSFORM: Translational Research that Adapts New Science FOR Maltreatment prevention

ABSTRACT - OVERALL CORE
Each year millions of young children and adolescents in the U.S. are reported to Child Protective agencies for
maltreatment (neglect, physical, sexual, or emotional abuse), and experience additional forms of trauma such
as exposure to domestic abuse, community violence, life-threatening illness or injury, or sudden loss. A diverse
multidisciplinary team of investigators from the Universities of Rochester and Minnesota will partner with the
NICHD to create the TRANSFORM Center (Translational Research that Adapts New Science FOR
Maltreatment Prevention) to prevent child maltreatment and to address its sequelae. The unique combined
capacity of this multi-investigator Center, i.e., the expertise, infrastructure support, human/fiscal resources, and
research/intervention strategies would not be feasible for a single investigator working alone in one laboratory.
Building on current state-of-the-science research methodologies and clinical practices that address the
personal and societal burden associated with child abuse and neglect, TRANSFORM will leverage
theoretically-grounded evidence-based research and preventive interventions to optimize outcomes in children.
In doing so, the Center will apply the most advanced concepts and methods derived from child maltreatment
research, and leverage numerous longstanding relationships within the child welfare community to make its
impact. TRANSFORM will use a multidisciplinary translational approach embedded in a developmental
psychopathology framework that builds upon discoveries in genetics, neuroscience, prevention and
intervention science, child welfare, and court systems to develop an innovative national resource for diverse
disciplines and professional arenas. To achieve its objectives, TRANSFORM will utilize two Research Projects
and two mutually-informative and integrated Cores: a Community Engagement Core, and an Administrative
Core. This `team science' model brings together professionals with different backgrounds including basic and
applied scientists who provide the theoretical grounding for project hypotheses, program developers who are
the architects of evidence-based programs, research methodologists who advise on the appropriate
experimental designs for testing the models, including the constructs and measures that will map onto the
mediators and moderators, the analytical methods for evaluating results, attorneys who can translate results
into legal and judicial systems, and child-serving professionals and governmental stakeholders who will
participate in dissemination activities. TRANSFORM will be led by Drs. Sheree Toth and Dante Cicchetti,
internationally-recognized leaders in the field of child maltreatment, whose collaborative work spans almost
four decades and provides a solid foundation for conducting groundbreaking longitudinal and prevention
research that will contribute to widespread engagement across multiple child-serving systems.

Public health relevance
PROJECT NARRATIVE To advance the field of child maltreatment, a diverse and multidisciplinary team of investigators from the Universities of Rochester and Minnesota will partner with the NICHD to create the TRANSFORM Center (Translational Research that Adapts New Science FOR Maltreatment Prevention). Building on current state-of- the-art research methodologies and clinical practices that address the personal and societal burden associated with child abuse and neglect, TRANSFORM will leverage theoretically-grounded evidence-based research and interventions to optimize outcomes in children. A broad audience of investigators, child-serving professionals, parental, and governmental stakeholders will be the target audiences for community engagement, dissemination, and outreach activities.